Neural circuit basis of safety learning

ABSTRACT
Learning about and using environmental cues for safety is critical for survival and mental wellbeing. Current
research on safety signals identiﬁes the basolateral amygdala, insular cortex and infralimbic prefrontal cortex as
important components of the neural circuits needed to process safety signals. These structures are anatomically
interconnected and the proposed studies will be the ﬁrst to test whether they work together in response to safety
signals to mediate safety learning and fear inhibition. Prior mechanistic and descriptive electrophysiology
experiments point to the amygdala and insula as key sites for safety learning but not necessarily for recall. Aim 1
will test the hypothesis that basolateral amygdala neurons that project to the insular cortex convey information
about the safety signal and are necessary for safety learning. In contrast, the infralimbic cortex is responsive to
already learned safety signals and is thought to be critical for behavioral inhibition during threat. Aim 2 will test the
hypothesis that infralimbic neurons which receive input from the insular cortex are critical for fear inhibition by
safety signals. The results will help complete our understanding of the neural mechanisms underlying safety
learning and provide a basis for understanding abnormal safety related behavior in psychopathology.

Public health relevance
Narrative Learning the diﬀerence between safety and danger is critical to survival, yet learning and using safety signals is impaired in some psychiatric conditions including posttraumatic stress disorder (PTSD). Safety learning requires plasticity within the insular cortex and the proposed work investigates the nature of safety and danger signal coding in neurons of an anatomically deﬁned amygdala-insula-prefrontal circuit hypothesized to be necessary for learning and using safety signals to regulate fear. Functional and structural insular cortex abnormalities are reported in individuals with PTSD and other psychiatric conditions and the resulting data will inform pathophysiological mechanisms and new avenues for treatment development.